Our Voices Matter: Racial Justice Activism Intervention to Address Structural Racism and Prevent Depression in Black and Latinx Youth

PROJECT SUMMARY/ABSTRACT
Over 15 million people participated in racial justice protests nationwide, following the murders of George Floyd
and Breonna Taylor, spotlighting activism as a collective tool against structural racism and discrimination
(SRD). SRD manifests as policies and practices (e.g., redlining, voter suppression, mass incarceration) that
produce hostile environments which contribute to psychological distress, elevated allostatic load, and an
elevated risk for chronic diseases and premature death, concentrated within Black and Latinx populations.
While the connection between SRD and health is well documented, few studies provide evidence on strategies
to reduce SRD and mitigate consequences on psychological and physiological outcomes. Thus, there is a
critical need to rigorously test interventions that address the root causes of SRD and reduce SRD’s influence
on the mental and physical health of Black and Latinx populations, beginning in adolescence. The specific
aims of the study are to 1) Determine whether a racial justice activism behavioral intervention prevents and
reduces depressive symptoms in Black and Latinx adolescents and young adults and 2) Determine whether a
racial justice activism behavioral intervention lowers allostatic load scores in Black and Latinx adolescents and
young adults. To accomplish these aims, the team will conduct a stage II group-based, multi-component, and
multilevel randomized behavioral clinical trial. We will collect psychological and physiological measures at
baseline, then at 6-month intervals for 2 years post racial justice activism intervention.

Public health relevance
PROJECT NARRATIVE Inequities in access to power, resources, and services based on structural racism and discrimination (SRD), can manifest as policies and practices that can cause psychological distress, elevated allostatic load, and elevated risk of chronic diseases for Black and Latinx populations. While the connection between SRD and health is well documented, few studies provide evidence on strategies to reduce SRD and mitigate consequences on psychological and physiological outcomes. This project uses a randomized, behavioral clinical trial to test racial justice activism (RJA) as an effective intervention to mitigate depression and allostatic load in Black and Latinx adolescents and young adults, impacted by SRD.